KGF INHIBITS CELL FALLING AWAY &ARTERY DIMINUTION IN PRIMATE ENDOMETRIUM

In primates, progesterone (P) upregulates endometrial keratinocyte growth factor (KGF), especially in the stromal cells of the basalis zone and around spiral arteries (Koji et al, J. Cell Biol., 1994). When P levels decline at the end of the luteal phase, KGF mRNA drops ~9-fold, the upper endometrial zones undergo menstrual breakdown and the basalis undergoes apoptotic cell death. We replaced KGF by systemic administration during P-withdrawal in order to evaluate its effects on menses, apoptosis and spiral artery growth. Juvenile rhesus monkeys were ovariectomized and treated sequentially with estradiol and P implants to induce menstrual cycles. In the test cycle, KGF (5 mg/kg or 1.5 mg/kg) or PBS was administered daily IV for 5 days, beginning 1 day before the P implant was withdrawn. On day 4 of P withdrawal, the uterus was removed. KGF substantially inhibited apoptosis in the basalis zone (mean apoptotic index = 0.58 vs 4.32 for KGF vs PBS treatments, respectively). Spiral artery dimensions, measured as arterial profiles/unit area in histological sections, were 5-fold greater in KGF-treated (ratio = 0.12) compared to saline-treated (ratio = 0.024) animals. There was no evidence that KGF enhanced proliferation or inhibited menstrual breakdown in the upper functionalis zone. In summary, replacement of KGF during P-withdrawal protected basalis cells against apoptosis and maintained the spiral arteries in a hypertrophied state without inhibiting menses. During the luteal phase, KGF may function to mediate the trophic effects of P on both the spiral arteries and the glands of the basalis in the rhesus macaque endometrium.